Uterine infection and infertility: how microbial infection of the reproductive tract causes ovarian dysfunction.

Project summary Bacterial infections of the female reproductive tract are common in both women and dairy cows. These uterine infections cause infertility in both species, but the specific mechanisms resulting in a failure to conceive remains unclear. Emerging evidence suggest that the infection impacts ovarian health, and that ovarian problems are important causes of the infertility associated with uterine infection. Pathogen-associated molecules which initiate inflammation are concentrated in the follicular fluid of dairy cows with uterine infection and ovarian function is disrupted resulting in extended luteal phases, less sex hormone production, localized inflammatory responses and reduced oocyte quality. Furthermore, exposure of bovine ovarian explants or mice to pathogen-associated molecules accelerates activation of the primordial follicle reserve, suggesting that infection may deplete the total number of follicles available in the ovary and reduce overall long-term fertility. In women, pelvic inflammatory disease results from bacterial infection of the reproductive tract with common sexually transmitted pathogens. Infertility affects 10% of PID patients, and ovarian pathology is a component of this disease, including depletion of the follicle reserve. In addition, a higher proportion of IVF patients have suffered uterine infection, while patients with elevated Chlamydia antibody titers or pathogen-associated molecules in the reproductive tract have poor ovarian response and lower pregnancy rates. We hypothesize that pathogen-associated molecules, and ovarian follicle inflammatory responses to these molecules, compromises oocyte health and depletes the ovarian follicle reserve. This project will utilize an animal model of uterine infection to study the mechanisms of ovarian dysfunction in dairy cows. Aim 1 will focus on the impact of infection on the oocyte itself, while Aim 2 will focus on effects of uterine infection on ovarian follicle dynamics. These studies will allow us to determine the impact of infection on the oocyte and ovarian follicle in an appropriate in vivo system. In parallel we will utilize in vitro cellular and molecular techniques to determine the mechanisms by which infection results in ovarian dysfunction. Taken together we anticipate finding common mechanisms that link pathogen-associated molecules and inflammation with the dysfunction of oocytes and ovarian follicles. These discoveries will provide target mechanisms of action for using therapeutics to limit the impact of uterine disease on ovarian health. By understanding these mechanisms of ovarian dysfunction we can help protect fertility, or minimize the impact of infection on the ovary, by using pharmacological manipulations of the immune system and signaling pathways involved in infection-mediated infertility. The benefit of these studies to the NIH and USDA will be to increase the health and fecundity of women and dairy cows, resulting in more positive pregnancy outcomes in women and improving agricultural security and profitability for the dairy industry.

Public health relevance
Project narrative Bacterial infections of the uterus are very common in both women and dairy cows, and routinely cause infertility even after the resolution of infection. How uterine infection causes infertility is not well understood, but recently we discovered that uterine infection negatively impacts the ovary by disrupting follicle and oocyte development. This projects uses a unique and relevant animal model of infection to determine the mechanisms of how uterine infection results in infertility, providing us a much needed insight into the disease and ultimately improve fertility in women and dairy cows.